Administrative Core

PROJECT SUMMARY/ABSTRACT
The Administration Core will provide executive oversight and administrative support for all of the projects and
cores that comprise the Leukemia SPORE. The goal of the Administration Core is to monitor the activities of all
of the program components, to comply with all local and federal guideline for grant administration, and to
facilitate communication and collaboration among the program members and with other Leukemia SPOREs.
Accordingly, the specific aims of the Administration Core are as follows:
Aim 1. To facilitate intra- and inter-SPORE communication and collaboration.
Aim 2. To provide administrative and fiscal oversight and support for all SPORE components.
Aim 3. To coordinate administrative activities of the SPORE Developmental Research Program.
Aim 4. To coordinate the SPORE Career Enhancement Program.
Aim 5. To assist investigators with the preparation of scholarly presentations, publications, regulatory
documents, and all other SPORE-related paperwork.
Aim 6. To enhance participation of minorities in SPORE activities.
Aim 7. To ensure advocacy issues are addressed and included in all aspects of research with patient
participants.

Public health relevance
PROJECT NARRATIVE (2-3 SENTENCES) This shared resource will provide needed administrative support for the translational leukemia research proposed in this SPORE and facilitate collaboration between other SPORE institutions.